The role of lineage in the temporospatial genesis of retinal bipolar cell subtypes

PROJECT SUMMARY / ABSTRACT
The retina is a cellularly complex tissue comprised of over 100 different cell types which work together to
enable proprer vision. Bipolar cells are a diverse class of interneurons that connect rod and cone
photoreceptors to retinal ganglion cells, the projection neurons of the retina, which then in turn send their
output to the brain. There are currently 15 known subtypes of bipolar cells that differ in their connectivity,
physiological responses to light, morphology, abundance, and gene expression profiles. A recent
developmental study from our lab performed birthdating analysis to determine when different bipolar cell
subtypes were born and found that bipolar cell subtype genesis was arranged into concentrated domains that
changed over developmental time. When these domains were compared over time, they formed a wave-like
temporospatial pattern of bipolar subtype genesis that spread over the entire extent of the retina. This result
suggests a hierarchical model of bipolar subtype genesis in which early retinal progenitor cells generate a
series of sub-lineages off-set in developmental time, that undergo a temporally ordered production of bipolar
subtypes. To investigate this potential model, I have invented a novel molecular tool called SCRIBE
(Sequential Combinatorial Recorder for Iterative Barcode Evolution) that functions as an “evolvable” lineage
recorder. By iteratively adding barcode fragments to a genomic target site, SCRIBE aims to generate an
evolving, heritable sequence that can be used to distinguish between sister sub-lineages across multiple levels
of a clonal lineage tree. The goal of this proposal is to investagate how bipolar cell subtype specification is
achieved in development. During the mentored portion of this proposal (K99), I will further develop SCRIBE for
use in the in vivo retina and use it to investagate the temporal ordering of bipolar subtype production and the
lineage relationships between postnatal RPCs that generate bipolar cells. In the independent portion of the
proposal (R00), I will determine whether bipolar subtype specification is intrinsic or extrinsic, and investigate
potential molecular regulators of bipolar subtypes specification. The completion of these aims will provide me
with training in the fields of retinal development and cutting-edge molecular tool development, complementing
my previous training experiences. I will perform the mentored portion of this proposal under the supervision of
Dr. Constance Cepko who has been a leader in the fields of retinal development, lineage tracing, and in vivo
molecular tool development. Furthermore, the broader scientific environment surrounding the Cepko lab at
Harvard Medical School will provide outstanding training opportunities. Together, these experiences will
provide me with a solid foundation that will support my long-term career goal of leading my own independent
academic laboratory focused on studying the molecular bases of cellular diversity in the retina.

Public health relevance
PROJECT NARRATIVE The retina is a small, disc-shaped piece of tissue located in the back of the eye that is responsible for vision. During development of the retina, over 100 diffent types of cells are produced that work together to allow for proper vision. This project aims to study how the production of this enormous cell diversity is regulated during development to ensure that the correct number of each of these cell types are produced and that they are produced evenly across the surface of the retina.